Imaging and Neural Circuits Core

Imaging and Neural Circuits Core Summary
Opioid abuse and related deaths are rising exponentially, with synthetic opioids dominating the recent increase
in overdoses. The Imaging and Neural Circuits Core (INCC) is ideally situated to collaborate across UW and the
broader NIDA research community by developing publicly available imaging and modern circuit neuroscience
resources, alongside unique training opportunities focused on the high-resolution investigation of opioid circuits
and neurons that play a role in naturalistic motivated behavior, drug seeking, stress, anhedonia, and
reinstatement/relapse. Here, we propose to continue the existing capabilities and expand our resources for
investigating single cells and circuits in motivation, drug-seeking, and opioid neurobiology by integrating cutting-
edge genetic, electrophysiological, and imaging technologies. The central goals of this proposal are to i) facilitate
2-photon imaging and simultaneous holographic optogenetics in awake and behaving animals; ii) generate an
experimental pipeline for single-cell gene expression profiling of intact tissue volumes; iii) develop
instrumentation and training protocols for high-resolution Neuropixels electrophysiology and to further enhance
existing fiber photometry, 1p calcium imaging, and optogenetics instrumentation. The continuation of the existing
INCC infrastructure will integrate leading animal models of motivated behavior, non-contingent and contingent
administration of opioids together with high-resolution neural circuit analysis to provide critical resources that
enhance and facilitate basic science and training in addiction research at the University of Washington and
partnered Historically Black Colleges and Universities (HBCUs). This INCC proposal also includes the
expansion of cutting-edge high-density in vivo electrophysiology and light sheet microscopy coupled with
molecular feature identification pipelines. Together, the implementation of existing and new technologies in
neural circuit dissection and reward behavior will provide unique opportunities for undergraduate, graduate, and
post-doctoral trainees, as well as early-stage investigators across many disciplines and backgrounds to further
our understanding of the neurobiology of addiction.